Compounds that block a novel Candida albicans target

SUMMARY/ABSTRACT
Candida albicans is the most common pathogen causing invasive fungal infections. These infections are
dreaded complications of serious illnesses, and are estimated to lead to death in about 20% of patients. There
are very few treatment options for fungal infections. This is because many cellular components whose function
could be disrupted by drugs are similar between fungi and humans, leading to unacceptable toxicities to human
cells. We have identified a potential drug target in C. albicans which has no human homologs, and whose
inactivation leads to potentiation of drugs in 2 of the 3 major antifungal classes. This target is conserved among
3 phyla of pathogenic fungi, suggesting that small-molecule inhibitors could potentiate antifungal activity against
other fungal pathogens. Because it is a cell-surface transporter, inhibitors of this target are not susceptible to a
major multidrug-resistance mechanism of C. albicans, the induction of drug efflux pumps. Other features that
render it impervious to development of resistance are that it is not an essential protein, diminishing the selective
pressure during drug exposure, and that part of the mechanisms of action of its inhibitors may be its role in
virulence activities of the fungus. Virulence factors like hyphal growth and oxidative stress resistance are not
required during commensal growth, which comprises the majority of the C. albicans life cycle.
We engineered a C. albicans strain in which inhibition of our target of interest induces GFP expression. This
reporter strain is amenable to high-throughput screening using the HyperCyt platform developed at The
University of New Mexico. We propose to screen library collections of chemically well-defined compounds with
desirable physicochemical properties, and with existing data for other indications. Active compounds identified
in the screen will be prioritized by their effect in potentiating the “gold standard” antifungal amphotericin, by their
potency in blocking virulence factors (e.g. hyphal growth), as well as their toxicity window. In addition,
prioritization will involve compound physicochemical properties, chemical tractability, and binding efficiencies
using state-of-the-art post-screen triage approaches. Further validation tests will employ an engineered “test
tube cell” Saccharomyces cerevisiae strain, in which the target is expressed at the plasma membrane as the
only transporter of its substrate. Structure-activity relationships for chemotypes of prioritized hits will be
established early. Hit-to-lead medicinal chemistry will be performed on prioritized hits with a focus on low host
cell toxicity and physicochemical properties that support the advancement of compounds into in vivo
pharmacokinetics and efficacy experiments. This project will provide high-quality lead compounds for
further development as an antifungal potentiator, and potentially as a virulence-modifying single agent.

Public health relevance
NARRATIVE Treatment options for invasive candidiasis, the most common of deadly fungal infections, remain limited. We discovered a novel drug target in Candida albicans, a cell surface phosphate transporter, whose inhibition potentiates the activity of two major antifungal classes and diminishes virulence activities. Through high- throughput screening and medicinal chemistry, we will develop inhibitors of this target, whose mechanism of action is predicted to foil resistance development, to expand the options for antifungal therapy.